Identifying sleep targets to improve stroke outcomes

Abstract
Stroke is the leading cause of adult disability in the United States and the second leading cause of mortality
worldwide. The impact of stroke goes well beyond visible disability. Patient-reported outcomes (PROs) are now
recognized as critical assessments of post-stroke outcomes. Important PROs such as fatigue, depression, and
pain affect approximately half of stroke survivors and predict post-stroke disability, higher burden of care, and
worse physical health but the underlying mechanisms are poorly understood. Surprisingly, the contributions of
poor or inadequate sleep to PROs including post-stroke fatigue and traditional stroke outcomes have not been
well-studied but have direct implications for screening and treatment. This application represents an ancillary
study to the highly successful, ongoing Brain Attack Surveillance in Corpus Christi (BASIC) Project (R01
NS38916), recently renewed through March 2024. In this population-based stroke surveillance study within a
Texan bi-ethnic county, all acute ischemic stroke patients are interviewed and followed prospectively for 90-
day outcomes, including a comprehensive set of PROs. This unique epidemiologic sample, with equal
representation of non-Hispanic whites and Mexican Americans, allows for the exploration of effects of
disrupted sleep on fatigue and stroke outcomes in general and specifically in Mexican Americans, a subgroup
with higher stroke risk and worse stroke outcomes. This will be accomplished through application of state-of-
the-art comprehensive but feasible portable polysomnography and the addition of measures of post-stroke
fatigue to the BASIC Project. Incorporating polysomnography into our large, population-based stroke study
significantly enhances the feasibility to obtain detailed sleep metrics in the stroke population. This study will
represent the largest longitudinal study to-date of full polysomnography among stroke patients. These highly
translational aims will examine in a systematic manner the physiologic insight and clinical utility provided by
polysomnography in relation to traditional and more patient-relevant stroke outcomes. Identification of sleep
measures associated with poor stroke outcomes will identify potential treatment targets for stroke recovery and
a potential target to reduce an important ethnic health disparity.

Public health relevance
Project Narrative Leveraging the infrastructure of the parent BASIC project, we propose the largest study of polysomnography among stroke patients. This population-based study will comprehensively study sleep after stroke and assess associations with important stroke outcomes, including patient related outcomes, for the first time. This study will identify potential novel treatment targets for stroke recovery and explore a potential target to reduce an important ethnic health disparity.